Understanding hematopoietic stem cell dysfunction in refractory Crohn's disease

Despite an unprecedented growth in Crohn's disease (CD) therapies it has remained consistent that each new
therapy is less effective for patients that failed a previous therapy leaving many patients refractory to treatment.
While CD therapies seemingly encompass distinct therapeutic mechanisms, all target the inflammatory response
supporting that medically refractory CD involves mechanisms not directly related to inflammation. The near
universal success of autologous stem cell transplantation (SCT) in refractory CD provides a rare cohort to
understand therapeutic mechanisms that exist outside of the traditional CD treatment paradigm. In our study of
CD patients that received a SCT we strengthened previous associations between inflammatory macrophages
and refractory disease but further suggested a refractory phenotype is acquired through dysfunction of
hematopoietic stem cells (HSC) and progenitors that reinforce differentiation of aberrant myeloid cells unable to
support intestinal healing and rendering immunotherapy ineffective. As such, the central goal of this proposal
is to understand differences in hematopoietic progenitors associated with refractory CD and how hematopoietic
progenitor dysfunction determines clinical outcomes. This proposal will advance our understanding of CD
therapeutic mechanisms through (Aim 1) profiling of HSC populations associated with refractory CD and (Aim
2) characterizing HSC functions associated with refractory CD and therapeutic outcomes. In Aim 3 we will
explore a poorly defined intestinal HSC niche important to our long-term goal of understanding how myeloid
progenitors support intestinal populations that reinforce refractory disease or promote healing.

Public health relevance
PROJECT NARRATIVE While CD therapies seemingly encompass distinct therapeutic mechanisms, all target the inflammatory response supporting that medically refractory CD involves mechanisms not directly related to inflammation. We suggest that refractory disease is due to dysfunction of hematopoietic stem cells (HSC) that reinforce differentiation of aberrant myeloid cells unable to support intestinal healing and rendering immunotherapy ineffective. This proposal will explore how to circumvent treatment non-response through cellular and regenerative therapies outside of traditional approaches that only target inflammation and generate valuable datasets for the research community to the benefit of a vulnerable population of refractory CD patients.